Overcoming inequities in Pulse oximetry Through clinical InformatiCs (OPTIC)

Background/Significance: Pulse oximetry is the most common method to monitor arterial oxygen saturation
in patients in modern medicine. This technology reflects light off oxygenated blood to approximate the more
accurate arterial blood gas (ABG) tests. Recent findings demonstrate that pulse oximeters are more inaccurate
in patients with darker skin tones, likely due to interference by skin tone. Minority patients consequently
experience disproportionately more hidden hypoxemia (HH), which occurs when pulse oximetry overestimates
oxygen levels as within the normal range (≥ 88%) but demonstrate hypoxemia by the more accurate ABGs.
However, ABGs are painful to administer and only provide episodic data, so they are used less frequently than
pulse oximetry. Furthermore, minority patients are less likely to receive ABG tests, making it even more likely
that the problem is underestimated.
Innovation: Replacing our pulse oximeters will require significant investment and time. However, a two-
stage alternative solution is possible now, leveraging existing pulse oximetry hardware. HH causes patients to
have internal organ malfunction, which is reflected in abnormal vitals and laboratory values. We will develop
solutions in this multi-health system study (Duke Health, Emory Healthcare) spanning 9 hospitals. In Aim 1, we
use routinely-collected electronic health record (EHR) data to develop a machine learning (ML) model to predict
which patients are at high risk for HH. Furthermore, we use informative sampling to identify which patients may
best benefit from an ABG. Some of these informative patients may benefit from skin tone measurement. In Aim
2a, we measure skin tone using multiple methods - administered visual scales (Fitzpatrick, Monk) and color
measurement devices (colorimeters, spectrophotometers, mobile phone cameras) - across patients in hospitals
to predict the degree of pulse oximetry bias in critical illness. Using informative sampling in Aim 2b, we build on
Aim 2a patients to iteratively identify and test which factors best identify skin tones that will best improve our ML
models. Finally, we prospectively perform silent validation for Aims 1 and 2 models in Year 5.
Next steps: The results of this proposal will build silently validated, implementation-ready ML models that
can mitigate the impact of HH using current pulse oximetry hardware and EHR data. Furthermore, by measuring
skin tone, it can mitigate the impact of skin tone on pulse oximetry bias through new ML models when combined
with EHR data. Finally, this project will conduct silent validation to ensure temporal validity and understand the
impact within current workflows. Completing this project will form the foundation for two future R01 proposals to
conduct cluster randomized trials to test the implementation of EHR-only (Aim 1) and skin-tone augmented EHR
ML models (Aim 2) to mitigate the effects of pulse oximetry inequity in current clinical practice.

Public health relevance
This project aims to mitigate hidden hypoxemia (HH), which occurs when pulse oximeters overestimate oxygen levels in patients with darker skin tones, leading to worse outcomes and health disparities. We propose a two- stage solution leveraging existing pulse oximetry hardware and electronic health record (EHR) data to identify and mitigate the impact of HH. The results of this project will provide implementation-ready ML models that can improve patient care and reduce health disparities caused by HH, laying the groundwork for future cluster randomized trials to test the effectiveness of our ML models in clinical practice.